Unraveling The Mechanism of Heart Failure in Hypertrophic Cardiomyopathy with Exercise CMR

Project Summary
Hypertrophic cardiomyopathy (HCM) is the most common genetic heart disease, with heart failure (HF)
being the most common adverse complication and cause of death. HCM comprises two distinct
phenotypes: with and without left ventricular outflow tract (LVOT) obstruction. There are established
pharmacotherapy and surgical options for treating obstructive HCM patients. Mavacamten (i.e., "mava"),
a cardiac myosin inhibitor (CMI), is the first pharmaceutical to gain FDA approval to treat obstructive
HCM. Despite enthusiasm for CMI, critical knowledge gaps exist, including long-term efficacy, safety,
and cost. Furthermore, it is unknown how potential improvements in cardiac remodeling between mava
compare to the “gold standard” invasive therapy of surgical myectomy. There is also a growing interest
in expanding indications for CMI to modify the natural history of the disease. Therefore, there is an unmet
need for improved phenotyping of HCM beyond classical LVOT obstruction to characterize the key
pathophysiologic mechanisms of HF symptoms and their response to CMI.
Cardiac magnetic resonance imaging (CMR) has become a modality well-suited to characterize the
HCM phenotype. Imaging of fibrosis and scar using T1, extracellular volume, and late gadolinium
enhancement imaging has prognostic value in HCM. In addition to evaluating LV function and volumes,
CMR can uniquely provide information on the right ventricle and left atrium, both of which are highly
involved in the pathophysiology of HCM. Quantitative myocardial perfusion is emerging as an objective
approach to assess myocardial blood flow for quantifying microvascular dysfunction. Cardiac diffusion
tensor imaging enables the evaluation of myofiber architecture, a histologically abnormal tissue property
in HCM. Cardiac spectroscopy provides a window into the cardiac energetics of the heart, a hallmark of
HCM pathophysiology. More importantly, our recent technical advances allow accurate and reproducible
quantification of the cardiac functional reserve with physiological exercise (Ex-CMR). Ex-CMR enables
quantification of cardiac function and structural changes in response to exercise, highly relevant
parameters associated with HF symptoms. In HCM patients with persistent symptoms despite gradient
relief with mava and in symptomatic non-obstructive HCM patients, we hypothesize that abnormal
pathophysiology in cardiac energy deficiency along with decreased myocardial blood flow from small
vessels leads to
oxygen supply-demand mismatch and ultimately promotes impaired diastolic relaxation,
with the inability to appropriately augment stroke volume with exercise. Therefore, we aim to improve our
understanding of HF in HCM through novel Ex-CMR image phenotyping. Our findings will improve HCM
patient management by targeting disease-specific abnormalities in a more personalized approach using
novel CMI pharmacotherapies or established surgical treatments.

Public health relevance
Project Narrative Heart failure (HF) is the most common adverse complication and cause of death in hypertrophic cardiomyopathy (HCM). With the robust capability to probe myocardial tissue composition, micro- to macro-structure, function, fibrosis, and energetics, cardiac magnetic resonance imaging (CMR) has emerged as an imaging modality well suited to characterize HCM pathophysiology. This proposal aims to improve our understanding of HF in HCM and its treatment with established and novel therapies.